J. NRSA Training Core (TL1)

A critical barrier to realizing the promise of the Academic Learning Health System (aLHS) is the insufficient
number of investigators with the skills to cross the research-practice chasm and create health systems in which
new knowledge is woven into the tapestry of clinical practice. The realization of the aLHS requires a new
translational workforce phenotype – the aLHS Translational Scientist – who is grounded in several rapidly
evolving, but infrequently integrated knowledge domains, including: 1) biomedical informatics; 2) improvement
and implementation science; 3) system science and organizational change management; 4) stakeholder
engagement, leadership, and research management; 5) ethics of health systems research; and 6) health
systems research methods. This new TL1 application proposes an innovative Academic Learning Health System
Scholars Program (aLHSSP) to provide the next generation of translational scientists with the methodologic and
professional skills to conduct rigorous research in the complex environments of health systems and to
disseminate and implement findings from such research into practice. The aLHSSP will target outstanding
candidates who have completed doctoral-level clinical training in medicine and other health professions
disciplines, as well as PhD prepared translational scientists who wish to conduct aLHS research. The program
offers 1- and 2-year tracks that will lead to either a Certificate in Learning Health System Science or Master of
Science in Learning Health System Science. All trainees will participate in a curriculum designed to build
competence in the knowledge domains listed above and will receive team science training to better prepare them
to conduct research in an aLHS and to lead research teams. Trainees will conduct a mentored research project
to address a pressing health system issue that will be guided by teams of experienced and committed faculty
who are subject-matter experts and well-grounded in the principles of effective mentoring. Advisors will include
top leaders in the Wake Forest Health System. The pool of mentors will be expanded through CTSI Faculty
Mentor Academy, a 10-session, 20-hour curriculum that addresses 6 core mentoring competencies and enrolls
12 mid-career and early senior faculty per year. The aLHSSP will be part of an integrated educational
infrastructure at Wake Forest that also includes our successful KL2 and Translational Workforce Development
Programs. Our structure will ensure that aLHSSP trainees will be prepared to write competitive KL2 or external
Career Development proposals or progress to early-career positions focused on aLHS research. Furthermore,
we will disseminate our curriculum and novel online learning platform throughout the CTSA network; a number
of Hubs have already expressed interest in these elements. The aLHSSP will provide a unique postdoctoral
training experience at Wake Forest. It represents a needed element in our ultimate goal of supporting our
evolution as a model academic learning health system.

Public health relevance
This new TL1 application proposes an innovative Academic Learning Healthcare System Scholars Program (aLHSSP) to provide the next generation of translational scientists with the methodologic and professional skills to a) conduct rigorous research in the complex environments of health systems, and b) disseminate and implement findings from such research into practice. The aLHSSP will offer 1- and 2-year tracks that will lead to either a Certificate in Learning Health System Science or Master of Science in Learning Health System Science; trainees will also conduct a mentored research project to address a pressing health system issue. They will be guided by teams of experienced and committed faculty who are subject-matter experts and well-grounded in the principles of effective mentoring; advisors will include top leaders in the Wake Forest Health System.